Mechanisms of adaptation to interbacterial antagonism by the human gut microbiota

The impact of the gut microbiota on human health depends on the identity of the species
therein. The mechanisms that lead to differences in microbiota composition between people is
not well understood. We focus on interbacterial interactions between members of the dominant
taxon in the gut of Western adults, the order Bacteroidales. These bacteria compete for space
and nutrients via a molecular nanoweapon known as the type VI secretion system (T6SS). Toxic
protein effectors delivered between adjacent Bacteroidales cells by the T6SS result in cell statis
or lysis, and we and others have previously revealed that this competition results in strain-level
differences in the microbiota through exclusion of target bacteria via killing. Since effectors can
be delivered indiscriminately to kin cells, T6SS-encoding bacteria produce immunity factors that
specifically neutralize cognate effectors. We have previously identified the pervasive presence
of “orphan” immunity factors encoded within large genomic arrays within Bacteroidales
genomes that lack cognate effectors. These acquired interbacterial defense (AID) systems
render the T6SS ineffective through neutralization of cognate effectors and facilitate strain-
exclusion from microbiomes. In this proposal, we seek to understand the mechanism by which
orphan immunity genes are captured aggregated into the most common type of AID system, the
recombinase-associated AID (rAID) system, using a powerful combination of bacterial genetics,
biochemistry, metagenomics, and gnotobiology. We further seek to understand the regulation
and biogeographical role of rAID systems through a hypothesized “competition-sensing”
mechanism that involves a hybrid sensor-kinase pathway. Together, we aim to understand the
impact of Bacteroidales defense against the T6SS on the gut microbiome.

Public health relevance
PROJECT NARRATIVE The bacterial residents of the gut impact human health. The specific makeup of these bacterial communities can differ dramatically between people, yet how these differences arise is not understood. My research combines computational analyses with experimentation to generate unique insights into the forces that sculpt the inhabitants of the human gut, through the lens of interbacterial antagonism and defense.